Improving Diagnostic Strategies for Post-Tuberculosis Lung Disease in Ugandan Primary Healthcare Settings

PROJECT SUMMARY /ABSTRACT
Prior infection with tuberculosis (TB) is increasingly recognized as an important risk factor for chronic
respiratory disease and reduced quality of life. Patients with a history of TB have up to three times the risk of
developing chronic lung disease at a younger age than their counterparts. However, TB programs are focused
on screening and treatment of the acute infectious disease. Despite a good treatment success rate for drug-
susceptible TB, many survivors do not return to full health. It is not known if health workers are aware of the
post-TB morbidity since standard diagnostic criteria for post-TB lung disease applicable to low-income
settings is currently under development. I hypothesize that health workers in our setting are unable to make a
diagnosis of post-TB lung disease due to a non-existent diagnostic tool. The overarching goal for this K43
training grant is to develop and assess the feasibility of a post-TB lung disease diagnostic tool based on history
and physical exam that can be easily deployed in a primary health care setting without access to specialized
diagnostic procedures. The proposed studies and formal educational activities in this proposal will provide
critical research training in three main areas; (a) risk modelling to create and validate a clinical diagnostic
algorithm, (b) qualitative work to determine health workers’ knowledge and attitudes towards diagnosis of post-
TB lung disease, (c) development and feasibility testing of an intervention for post-TB lung disease diagnosis in
a setting with limited diagnostic resources. I will build on an existing cohort of adults who have been declared
cured of TB at a tertiary hospital in Uganda to design and validate a diagnostic algorithm for post-TB lung
disease (Aim 1). I will conduct a qualitative study to identify healthcare provider barriers and facilitators of
diagnosing post-TB lung disease (Aim 2). I will subsequently determine the feasibility and acceptability of using
the post-TB lung disease diagnostic algorithm at a primary health-care facilities in Uganda in a pilot
intervention study (Aim 3). The findings of this proposal will have significant public health impact by improving
the diagnosis of post-TB lung disease in a low-income TB endemic setting. Importantly, I will add to the
growing body of post-TB lung disease literature, with potential generalization to other low-income settings. A
collateral output of this training grant is that I will improve on post-TB lung disease knowledge among
gatekeeper health facilities in our setting. The proposed mixed methods training will be the basis for my
transition to an independent researcher and will provide important preliminary data for a competitive NIH-R01
grant proposal. In the fourth year of this award, I will develop an NIH-R01 protocol to conduct a larger
effectiveness trial, or incorporation into trials of therapeutics for post-TB lung disease and ultimately improve
person-centered post-TB lung disease care quality and outcomes in TB endemic areas.

Public health relevance
Project narrative Globally, over 58 million pulmonary tuberculosis (TB) survivors are at a high risk of developing chronic lung disease that leads to early death and an impaired health-related quality of life. Addressing the important gap for post-TB lung disease in TB endemic areas where respiratory symptoms are often attributed to recurrent TB infection is the central aim of this proposal. We will develop and test a clinical algorithm for timely diagnosis of post-TB lung disease in Uganda with an ultimate goal of improving the care of TB survivors worldwide.